Epitope alteration for detecting auto-antibodies of beta-amyloid in serum

Alzheimer’s disease (AD) is an emerging public health crisis that poses a huge societal burden. The total
payments in 2015 for all individuals with AD are estimated at $226 billion in US. To reduce the cost of AD
care, inexpensive preliminary screening with a primary-care setting is one of the keys. However, currently
available imaging diagnostic technologies, such as expensive PET imaging, are nearly prohibitive for this
need. Clearly, fast, cheap, and reliable methods for preliminary screening of AD patients are urgently
needed. Compared to non-invasive imaging such as PET imaging and MRI imaging, biomarker detection
in biofluids is a very promising alternative for AD diagnosis. Currently, several methods, including immune-
MS, ELISA, SIMOA, have been tested in clinical trials; however, these methods are associated with certain
drawbacks. For example, immune-MS is tedious, while SIMOA has low accuracy and ELISA has large
variations from different labs.
Mounting evidence suggest that the adaptive and innate immune systems play essential roles in AD
pathology. However, the exact roles of humoral immunity in AD pathology are still not clear. Accumulation
and aggregation of Beta-Amyloid (Aβ) peptides are hallmarks of AD, and the regulation of Aβ levels has
been one of the essential aspects for prevention and development of therapeutics. It is not surprising that
human immunological repertoire naturally has such a regulatory system to control the Aβ levels. Naturally
occurring autoantibodies (nAbs) against Aβ (nAbs-Aβ) are a part of the innate immune system with the
functions of controlling the metabolism and clearance of Aβ species in brains and periphery systems. Over
the past years, several studies have investigated nAbs-Aβ titers and their correlations with the stages of
AD or severity of AD. However, the reported results are contradictory. In this R21 application, we provide
a new angle to investigate nAbs-Aβ in human serum in hope of partially solving the inconsistence problem.
We previously discovered that antibody-epitope interactions can be tuned to higher or lower affinities by
small molecules for Aβ and tau proteins. Particularly, we found that CRANAD-Xs, a series of Aβ imaging
probes developed by the PI group, could enhance, or weaken the binding between Aβ and its antibodies.
In this application, we speculate that CRANAD-Xs have similar tuning function for Aβ auto-antibodies in
serum, and this tuning capacity can be used to differentiate sera from AD patients and healthy controls.
Our method is very straightforward, due to no modifications are needed for both the Aβ antigens and
CRANAD-Xs.

Public health relevance
Narrative The purpose of this application is to establish a novel diagnostic method via utilizing epitope alteration phenomenon to detect differences of auto-antibody of amyloid beta in serum of Alzheimer’s subjects. The proposed studies will be beneficial for future diagnosis and treatment of Alzheimer’s disease.